Cellular and functional heterogeneity of interhemispheric connections in the anterior olfactory nucleus

ABSTRACT
The olfactory system in most mammals begins with two unique air flows separated by a nasal septum. This
allows the olfactory epithelium contained in each nostril to receive odorant information independently from the
other. The mechanisms by which the brain combines these separate inputs to obtain perceptual unity remain
unknown. Given the lack of interhemispheric connections within the primary olfactory area, the olfactory bulb,
the combination of the lateralized input must lie within the olfactory cortex. The anterior olfactory nucleus (AON)
is the earliest olfactory cortical area to project interhemispherically, making it an excellent candidate for the
combination of bilateral olfactory information. As a primary sensory area that receives cortical input, the AON is
implicated in social behavior and olfactory memory. Signaling between the hemispheres of the AON is necessary
for some AON-dependent behaviors. However, the specific cell types involved in the interhemispheric AON
connection are unknown, as well as the functional changes within the AON that result from contralateral input.
Identifying the underlying circuitry within the AON is critical to understanding its role in the olfactory cortex and
olfactory-dependent behaviors. Therefore, I will identify the cell types that send and receive interhemispheric
projections in the AON through viral tracing. This will allow me to not only visualize the interhemispheric
connections but to assess the density of such connections in the various AON subregions. I will further
investigate the molecular identity of contralaterally-projecting AON neurons through single-nucleus RNA
sequencing. This will not only generate genetic markers of interhemispherically-projecting neurons but serve as
a resource for further study into the molecular diversity of the AON. To probe the functionality of the AON→AON
connection, I will assess the neuronal activity resulting from the stimulation of contralaterally-projecting axons
on the AON through in vitro whole-cell electrophysiology. Additionally, I will compare the response of the AON
to ipsilateral and contralateral olfactory bulb stimulation in vivo. The combination of in vitro and in vivo
electrophysiology will describe the synaptic currents resulting from the interhemispheric connection as well as
the role of interhemispheric connection in the AON’s response to physiologically relevant stimuli. This work will
contribute not just to our understanding of the AON, but also to the processing and computation done by the
olfactory cortex. Insights from the cellular and functional diversity within the AON will guide future research on
the role of the AON in olfactory-related disorders.

Public health relevance
PROJECT NARRATIVE The anterior olfactory nucleus (AON) is the first area of the brain region responsible for the sense of smell to send information to the other hemisphere of the brain. I will determine the specific types of neurons that send and receive information on each side of the AON and look at the electrical activity of this network when it is stimulated. Doing so will contribute to our understanding of how the brain processes and interprets odors.